Genetic and molecular basis for SRSF2 mutations in myelodysplasia

Mutations in genes encoding RNA splicing factors are the single most common class of genetic alterations in
patients with myelodysplastic syndromes (MDS). Recurrent mutations affecting SF3B1, SRSF2, and U2AF1
are the most common and occur as heterozygous point mutations at specific amino acid residues. In the first
two periods of funding of this award, we identified that mutations in SRSF2 confer an alteration of function
distinct from loss-of-function, discovered the molecular impacts of mutations in SRSF2 on RNA splicing and
binding, and identified potential therapeutic vulnerabilities of SRSF2-mutant cells.
Much of our prior work focused on identification of novel, unannotated RNA splicing events created by
mutations in SRSF2. In this proposal, we will leverage this knowledge to develop two novel approaches to
understand the mechanistic basis of and develop new therapies for SRSF2-mutant MDS. Firstly, we will utilize
our recently developed technology – termed synthetic introns – to harness the neomorphic change in splicing
created by mutations in RNA splicing factors to drive selective gene expression in SRSF2-mutant cells. These
synthetic RNA sequences are efficiently spliced in cells bearing mutant SRSF2, but unspliced in wild-type cells,
allowing for mutation-dependent protein production only in SRSF2-mutant cells. These synthetic introns will be
utilized to generate a comprehensive map of the RNA regulatory environment that modulates mis-splicing in
SRSF2-mutant MDS. This will include assessment of cis elements in mRNA as well as identification of specific
trans-acting factors that are required for mutant SRSF2-dependent mis-splicing. Additionally, the development
of optimized SRSF2 mutation-responsive synthetic introns here will enable future therapeutic approaches
reliant upon selective protein expression in SRSF2-mutant cells.
In addition to the above, we will develop novel immunotherapeutic approaches that harness the
stereotypical patterns of mis-splicing that characterize SRSF2-mutant MDS. Our prior work demonstrates that
mutations in SRSF2 generate novel, unannotated mRNAs which are not otherwise created in normal tissues.
We have therefore used these splicing changes to identify novel antigens arising from mutant SRSF2-
dependent mis-splicing which are presented by MHC class I on the mutant cell surface as well as identify
corresponding antigen-specific CD8+ T cells in MDS patients and characterize their phenotypes and T cell
receptors (TCRs). We now aim to comprehensively identify and functionally characterize endogenous antigen-
specific CD8+ T cells in SRSF2-mutant MDS patients and test the therapeutic potential of T cells engineered to
express a panel of patient-derived, SRSF2-mutant peptide-specific TCRs.
Ultimately, completing these aims will increase our mechanistic understanding of how MDS-associated
mutations in SRSF2 result in mis-splicing to drive MDS development as well as develop mechanism-based
therapeutic approaches that are highly selective for SRSF2-mutant cells.

Public health relevance
Mutations in the RNA splicing factor SRSF2 are very common in patients with myelodysplastic syndromes (MDS). In our first two periods of funding, we identified that SRSF2 mutations confer a change in RNA splicing activity, distinct from loss-of-function, which results in the generation of new mRNA isoforms in cells. We now aim to use this knowledge to improve our understanding of how SRSF2 mutations alter splicing and discover mutant SRSF2-induced abnormal neoantigens and their corresponding T cells in MDS patients.